Accelerated Resolution Therapy for Early Maladaptive Grief: A Clinical Trial

PROJECT SUMMARY/ABSTRACT
Maladaptive grief negatively impacts 25-40% of older adult family caregivers of persons with a serious chronic
illness, with adverse health outcomes including increased morbidity and mortality, reduced independence, and
diminished immune function.1-4 Losses associated with aging, such as the death of multiple close family and
friends, are highly traumatic and contribute to the devastating impact of maladaptive grief among older
adults.8,10 Brief, effective interventions that address maladaptive grief early in the grief trajectory are urgently
needed.
Accelerated Resolution Therapy (ART) is an evidence-based treatment for post-traumatic distress in civilians
and veterans14-17 that may be useful in alleviating maladaptive grief prior to bereavement and could prevent
prolonged, complicated grief following bereavement. We are proposing to test the efficacy of ART, a low-risk,
brief therapy with a strong theoretical rationale for treatment success in maladaptive grief and supported by the
promising results of our recently completed preliminary trial (R21AG056584). Additional aims of the study are
to examine changes in cognitive appraisal and integration of loss following ART using a mixed methods
approach and to evaluate personal, social, and psychological factors predictors of response.
During the proposed double blinded, randomized, controlled two arm clinical trial, 472 older adult family
caregivers from two different geographic locations will receive either ART or an educational program that is
matched for time and attention. Each participant will receive four sessions of either the ART intervention or the
control intervention. Data collection will occur at screening/enrollment (T1), at the end of the 4-session
intervention period (T2) and at 6-months (T3) and 12-months post bereavement (T4). A subgroup of 20
participants randomly assigned to ART will participate in semi-structured interviews to enhance understanding
of cognitive appraisal and integration of loss.
This trial will provide critical information on the efficacy of the ART intervention as a potential first-line treatment
option for pre-loss grief and preventative option for complicated grief and contribute new information about
characteristics of individuals most likely to benefit from ART.

Public health relevance
PROJECT NARRATIVE Older adult family caregivers experience highly stressful situations during the end stages of a loved one’s illness that limit their ability to effectively cope with grief and loss. This study will evaluate a brief psychological treatment for grief. The results of this study may lead to improvements in treating grief and loss among family caregivers, improving the health and quality of life of older adults.